Small molecule mimetics of Humanin that normalize neuronal p-Akt as novel therapeutics for AD

ABSTRACT (Supplement)
Humanin (HN), a 24-amino acid mitochondrial-derived peptide from the occipital lobe of postmortem sporadic
AD patient brain tissue [1] is a neuroprotective peptide that could protect neurons from Aβ-related and NMDA-
induced toxicity [2]. A decrease in the endogenous HN plasma level with age has been reported [3], and
decreased HN levels has been linked to cognitive decline during aging. The identification of a SNP (rs2854128)
using mitochondrial GWAS in the HN-coding region of the mitochondrial genome from a large sample of older
adults further supports the role of HN and its circulating levels with accelerated cognitive decline [4]. The
availability of high throughput screening (HTS) formattable assays, allow for screening to identify small molecules
that can enhance HN expression and its levels in AD models. In the parent grant we completed screening for
small molecules that act as humanin (HN) mimetics and have identified validated hits that increase both the p-
gp130 and p-Akt levels in neuronal cells. Further analoging, testing and evaluation of these mimetics are ongoing
following the path outlined in the grant. The availability of new assays to assess levels of HN peptide itself in
vitro and in tissue has presented the opportunity to also identify small molecules that enhance HN levels. Our
preliminary data using this assay shows that we can detect HN levels in SH-SY5Y cells. Hence for the
Supplement research we propose is to conduct screening for HN enhancers using the human neuroblastoma
SH-SY5Y cells that express and secrete HN [5]. The work we propose in the Supplement is directed toward
formatting of the available HN ELISA assay for HTS and screening of a subset of the UCLA compound library to
identify compounds that change HN levels in cells. Hits from the screening would be validated and then undergo
secondary testing to confirm HN enhancement in SH-SY5Y and iPSC-derived human neurons, as well as in
murine neuroblastoma N2a. Validated hits would also be assessed for increasing neuronal p-Akt. Thus, in the
supplement we propose an Expansion of Aim1 of the parent grant to include identification of HN enhancers
that along with our currently identified HN mimetics would undergo further testing and evaluation as outlined in
the parent grant. Hits from the screening would then undergo secondary testing to confirm HN enhancement in
SH-SY5Y and iPSC-derived human neurons, as well as in murine neuroblastoma N2a cells. Validated hits would
also be assessed using our p-Akt AlphaLISA to confirm biological activity in neurons. Validated HN enhancers
would undergo prioritization as part of Expansion of Aim3 of the parent grant by evaluation in in vitro ADME-T
assays. Prioritized analogs would undergo pharmacokinetic (PK) and pharmacodynamics (PD) studies to identify
brain permeable HN enhancers. Such an HN enhancers identified from the supplement grant would have the
potential to be developed as novel therapeutic candidates for Alzheimer's disease (AD), and could in the future
also be evaluated in other disorders such as diabetes and cardiovascular disease.

Public health relevance
PROJECT NARRATIVE (Supplement) This Administrative Supplement is focused on the expansion of our screening and testing to include identification of molecules that increase human (HN) levels, that in addition to HN mimetics we have identified in the parent grant, would be evaluated for their ability to normalize neuronal p-Akt. The availability of new assays to assess levels of HN itself in vitro and in tissue has presented the opportunity to identify small molecules that enhance HN in brain tissue. Such an enhancer would have the potential to be developed as a novel therapeutic for Alzheimer's disease (AD) and other disorders; the Supplement would include HTS of a subset of the UCLA compound library in human neuroblastoma cell using an HTS-formatted HN ELISA assay, validation of hits for HN enhancement in both SH-SY5Y cells and iPSC derived human neurons, in vitro ADME-T analysis for selection of best candidates for pharmacokinetic (PK)/pharmacodynamic (PD) testing to identify brain permeable HN enhancers.